Developmental Exposures to Arsenic: Pneumonia, Immunity, and Microbiomes (DEAPIM)

ABSTRACT
Exposure of human populations to arsenic via drinking water, air, and food is associated with significant
morbidity and mortality. Along with impairments in immune function, an increased susceptibility to pneumonia
has been observed in children exposed to high levels of arsenic. Pneumonia is a major global health concern
accounting for 70% of pediatric hospitalizations in the US alone. Epidemiological studies indicate a decrease in
the efficacy of respiratory vaccines in arsenic-exposed children. While vaccine efficacy is largely dependent on
host immune function, recent evidence indicates that the gut microbiome may also play a role. However, the
interrelationship of immune function and the microbiome on vaccine response in arsenic-exposed children has
not been studied. It is likely that early exposures to arsenic compromise vaccines protecting against
Streptococcus pneumoniae, the most common bacterial cause of pneumonia. The Scientific Premise is that
Early life and in utero arsenic exposure in children leads to alterations in adaptive immunity via dysregulation of
lymphocyte development and function. The impairment in these immune cells is responsible for decreases in
protection from upper airway infections (such as S. pneumoniae) due to decreased vaccine PCV10 efficacy, as
measured by S. pneumoniae nasopharyngeal (NP) carriage and anti-PCV circulating antibody titers. We also
posit that arsenic disrupts the gut microbiome which may alter vaccine efficacy, due to altered adaptive T cell
development. In Aim 1, we test the hypothesis that arsenic exposure in utero and during early life in children
(1-2 year) leads to (a) impaired PCV10 antibody responses following a booster dose of PCV10, and (b)
influences the NP microbiota diversity and the S. pneumoniae carriage. We will measure PCV10 titers and NP
carriage using qRT-PCR and full length 16s rRNA sequencing. In Aim 2, we test the hypothesis that alterations
in immune function and development are associated with early life arsenic exposure, leading to compromised
host immunity. These measures include PBMC immune biomarkers and functional immune assays including:
a) cell surface markers (CSM = T, B, NK, monocyte/dendritic cells, memory effector T cells) and the Th cell
subsets (Th1, Th2, Th4, Th17, Treg) using 11-color flow cytometry; b) T cell proliferation; c) ex vivo cytokine
production. In Aim 3 we test the hypothesis that differences in functional gut microbial composition are
influenced by immune development and immune function. We will assess the gut bacterial microbiome by
shotgun metagenomics and correlations with; a) PCV10 titers and the pneumococcal carriage (Aim1) and b)
changes in immune markers/function (Aim 2). The study will be conducted among 400 children in Bangladesh
ages between 1 and 2 years. Mothers of the participating children are part of a birth cohort and are followed
throughout their pregnancy, and children are extremely well characterized for arsenic exposure in utero. These
studies will provide new evidence on altered PCV vaccine response and the importance of the gut microbiome
in adverse health outcomes associated with arsenic.

Public health relevance
NARRATIVE We will examine the toxicity of arsenic to the developing immune system in children exposed in utero and early life and how it affects their response to vaccination against Streptococcus pneumoniae. It is known that arsenic disrupts the development of immune T cells important in protecting children against airway infections, such as Streptococcus pneumonia. We will measure how arsenic impacts the response to vaccination and microbial communities in the upper airways and gut.